The regulation and function of platelet FcARIIA in sepsis

PROJECT SUMMARY/ABSTRACT
This is an application for a K08 award for Dr. Elizabeth Middleton, a pulmonary and critical care physician at
the University of Utah. Dr. Middleton is establishing herself as a young investigator in translational research of
biological mechanisms driving the pathophysiology of sepsis. Her long-term goal is identification of new
therapeutic targets to advance the care of patients suffering with sepsis so they have longer and have
improved quality of life. The role of platelets in inflammation and infection is poorly understood. She is
proposing to investigate the contribution of the megakaryocytes (the platelet parent cell) and platelets, and how
they impact a patient’s response to sepsis. This K08 will provide Dr. Middleton with the support necessary to
accomplish the following goals: 1) gain expertise in megakaryocyte (MK) biology, gene expression, and
functional assessments, 2) to increase knowledge of platelet FcγRIIA biology and function through use of
humanized transgenic mouse model, 3) to develop the skills and toolsets to dissect intracellular platelet
signaling events, 4) expand skills to independently lead and manage a translational research program. To
achieve these goals, Dr. Middleton has assembled a mentoring team comprising a primary mentor, Dr.
Matthew Rondina, an established physician-investigator and leader in the field of platelet biology in immune
responses and inflammation, and 4 advisors who are leaders in the fields of megakaryocyte gene expression,
biology and function, translational research in sepsis and acute respiratory distress syndrome, and genetically
altered murine research.
The primary treatment for sepsis is early recognition and hemodynamic resuscitation, antibiotics and
supportive care. Despite hospital-based systems to detect the onset of sepsis, it continues to carry significant
mortality, short- and long-term morbidity. Dr. Middleton’s research focuses on the study of a platelet immune
receptor, Fc fragment of IgG receptor IIA (FcγRIIA), which is positioned at the cross-roads hemostatic,
immune, and inflammatory continuum. Dr. Middleton will (Aim 1) determine how platelet FcγRIIA expression is
increased in sepsis; (Aim 2) determine if increased platelet FcγRIIA during sepsis causes hyperactivation,
thrombosis, and mortality. In Aim 1, Dr. Middleton will investigate the inflammatory agonists that drive
increases in platelet FcγRIIA and track the expression of this receptor from the megakaryocyte to circulating
platelets. In Aim 2, Dr. Middleton will interrogate whether the increased platelet FcγRIIA contributes to risk of
thrombosis and short-term mortality associated with sepsis. This research will prepare Dr. Middleton to design
and implement a research program with clinical applicability to inform future therapies for sepsis.

Public health relevance
PROJECT NARRATIVE Sepsis is a common syndrome of dysregulated immune responses to infection that occurs in all ages and populations. Without a clear understanding of the complex biology that causes these responses we cannot provide effect treatments to minimize the risk of death or long-term complications. This proposal has the potential to uncover biology to lead to therapeutic improvements for the treatment of sepsis.